Gene Editing and Mouse Models Assessment (GEMMA) Core

GEMMA Core: Summary
The primary goal of the Gene Editing and Mouse Models Assessment (GEMMA) Core is to provide COBRE
project leaders and their staff access to facilities, expertise and training essential to execution of their projects
and establishing their research programs at the MRI. The GEMMA Core will also support non-COBRE faculty
and projects at the MRI and other institutions in Montana, increasing research capacity in the region by providing
access to transgenic, genotyping and neurobehavior services, consultation and training for mouse colony
maintenance and gene editing, and access to a shared research environment for conducting basic and
translational studies in a mentored environment. Three specific aims are proposed to accomplish the overall
goal: 1) provide transgenic and genotyping services needed to successfully execute experiments involving mice;
2) provide mouse colony management and training; and 3) develop a state-of-the-art mouse phenotyping service
in a shared research environment. This application is significant because it will provide a unique combination of
services, facilities and expertise to COBRE projects and other investigators working with mouse models across
the region, which will increase their success in obtaining independent NIH funding and performing impactful
research that advances our understanding of health and disease. It is innovative because it delivers these
resources to scientists in the northern Rocky Mountain front and surrounding area in a collaborative research
environment and provides employment opportunities in the field of biomedical research in an underserved region.
In addition, the shared research laboratory, neurobehavior and phenotyping facilities provide a supportive
environment and novel model across the spectrum of “research readiness” to spur research expansion while
also implementing innovative mouse handling techniques of compassionate care that minimize stress-related
behaviors. The GEMMA Core is integral to the success of our COBRE program and maintaining a sustainable
Center of Excellence in the long-term.